Leveraging gnotobiotic models to study the gut microbiota and anti-tumor immunity

PROJECT SUMMARY
Immunotherapy has been celebrated as a breakthrough cancer treatment, but despite this success, most
patients fail to respond to treatment. Growing evidence indicates that the intestinal microbiota can contribute to
responsiveness to immunotherapy. The gut represents a key site for immune regulation, and the delicate balance
between immune surveillance and tolerance can fluctuate in response to changes in the microbiota,
subsequently influencing systemic immunity and affecting extra-intestinal diseases (21). We and others have
found that colonization with specific bacterial species in mice was sufficient to enhance anti-tumor immunity and
augment immunotherapy (2, 22). We observed that oral administration of a Bifidobacterium cocktail alone was
sufficient to improve tumor control and enhanced the efficacy of immunotherapy anti-PD-L1 (2). The benefit
derived from Bifidobacterium appears to be connected to augmented dendritic cell function and CD8+ T cell
priming. While this prior study identified key characters orchestrating this microbiota-based effect, the link
connecting specific commensals in the gut to improved tumor control at distant sites is unclear, and whether
extensions can be made to human health and cancer patients was previously unknown.
My objective during my Ph.D. is to determine whether we can observe similar phenomenon in cancer
patients, and to identify how intestinal commensals distantly affect the tumor microenvironment. Consistent with
our preclinical data, we and others have found certain taxa associated with response to immune checkpoint
blockade in cancer patients (1, 19, 20). Provocatively, we also observed that germ-free mice colonized with
responder patient fecal material exhibited more robust anti-tumor immunity and derived greater benefit from anti-
PD-L1 therapy compared to mice colonized by a non-responder. These data support a causal role for the gut
microbiota in improved immunotherapy efficacy. I hypothesize that microbiota-dependent differences in anti-
tumor immunity can be attributed to 1) microbially-derived or -induced circulating factors, 2) cells under local
microbial influence at the intestine that migrate to the tumor, or 3) a combination of systemic and cellular factors.
Methods to engineer model bacterial systems are rapidly evolving (13-16). These tools enable us to test
hypothesis generated from mining databases with patient stool metagenomics data. The microbiome of cancer
patients has not yet been interrogated to discover microbial compounds linked to patient response. In my post-
doctoral work, I plan to focus on computational and synthetic biology approaches to find bacterial biosynthetic
gene clusters and evaluate these gene products anti-tumor immune potentiating properties. I hypothesize that
gene clusters overrepresented in the microbiome of patients that respond to immunotherapy can be expressed
in heterologous bacterial systems to identify anti-cancer or immune-potentiating small molecules. My overarching
goal is to continue building on the advances in this rapidly advancing field of the microbiome and cancer that will
translate into clinical action.

Public health relevance
PROJECT NARRATIVE Evidence from our laboratory have indicated that gut microbiota plays a key role determining outcome for cancer patients treated with immunotherapy, however, the mechanism by which bacteria within the gut can impact immunity at a distant tumor site remains largely obscure. To address these knowledge gaps, during the remainder of my Ph.D. I intend to work towards identifying how the microbially sourced signal reaches the tumor microenvironment, and to determine the key pathways and cell types involved. In my post-doctoral research, I aim to bioinformatically mine patient stool metagenomics for biosynthetic gene clusters associated with response to immunotherapy, and using synthetic biology approaches study the product of these genes to assess immune potentiating or anti-tumorigenic capacity.